GROWTH STUDY EVALUATING POWDERED FORMULA DESIGNED FOR LOW BIRTH WT INFANT

This study will determine whether a powdered formula with a specific dilution providing 22 kcal/fl oz and beta carotene, and more minerals, proteins and vitamins per calorie, as well as an alternate fat blend, permits greater growth and improved protein status in preterm infants after discharge from the hospital that a standard powdered term formula (Similac with iron powder).